Administration Module

SUMMARY – ADMINISTRATIVE MODULE
The Administrative module of the Core Grant provides oversight for each of the Resource and Service modules
to ensure that they are operated efficiently and to the maximal benefit of our participating faculty, that the funds
are utilized in a fiscally responsible manner, and that our approach is strategic and creative with respect to
current and future vision research of our participating faculty.